Defining receptor-ligand interactions in gastric epithelial immunosurveillance

SUMMARY
Stomach infections with H. pylori are a significant cause of morbidity and mortality, leading to chronic
gastritis, peptic ulcer disease and gastric cancer. While significant research efforts have been devoted to
studying H. pylori-induced gastric pathogenesis and inflammation, the immune mechanisms specific to the
gastric mucosa are still not very well understood. Importantly, how mononuclear phagocytes (MNPs) in the
stomach access the luminal H. pylori bacteria for stimulation and regulation of T cell responses is unclear.
Unlike the intestine, the stomach lacks M cells that are specialized for antigen transport from the lumen to the
lamina propria. However, a large proportion of gastric MNPs are positioned in direct contact with the gastric
epithelial layer, which likely supports efficient epithelial immunosurveillance including transepithelial dendrite
formation by the MNPs. The receptors and ligands that control these functionally important adhesive
interactions between the gastric epithelium and the MNPs are unknown. In preliminary studies, we have
identified homotypic interactions between E-cadherin (E-cad) expressed on the epithelial cells and E-cad
expressed by a subset of gastric MNPs as a potential candidate mechanism for MNP binding to the gastric
epithelium. The overarching goal of the current proposal is to identify the receptor-ligand (R-L) interactions that
MNPs in the stomach utilize to adhere to the gastric epithelium and to define the functional outcome of these
interactions for gastric immunity. In Specific Aim 1, we will determine the role of E-cad-mediated MNP-
epithelial cell engagement for MNP function in H. pylori infection. To achieve this aim, we will perform H. pylori
infection experiments in MNP-organoid co-cultures with and without E-cad inhibition and in two novel
transgenic mouse models with MNP-specific E-cad deletions, and we will map the distribution of E-cad+ MNPs
in the stomach of healthy and H. pylori-infected individuals. In Specific Aim 2, we will utilize single cell RNA
sequencing in gastric epithelial cell and MNP preparations to identify and evaluate additional receptors and
ligands that mediate cell-cell interactions between gastric MNPs and epithelial cells. Identified candidate
receptor-ligand pairs will be validated by analyzing gastric tissue sections and in functional experiments. Our
research is conceptually innovative, because it addresses the role of MNP E-cad expression in the stomach
and because it will identify receptor-ligand interactions that MNPs in the gastrointestinal tract utilize to interact
with the epithelial layer. The proposed research is significant, because understanding the mechanisms of
gastric epithelial immunosurveillance and adhesion by MNPs may ultimately inform the development of novel
strategies to modulate the gastric response to H. pylori and combat infection.

Public health relevance
PROJECT NARRATIVE Helicobacter pylori is a common bacterial pathogen and the major risk factor for peptic ulcer disease and stomach cancer. Understanding how immune cells in the stomach respond to H. pylori is important to design new treatment and preventive strategies to combat H. pylori infection. We here will analyze the molecular mechanisms that certain gastric immune cells – dendritic cells and macrophages – utilize to interact with the epithelial layer so they can access H. pylori bacteria that colonize the gastric lumen.